The Impact of In Utero E-Cigarette Exposure on Platelet Function and Thrombogenesis

While smoking has been on the decline, e-cigarette usage has been on the rise; especially in vulnerable
populations, including pregnant women, who switch to e-cigarettes due to misperceptions regarding their safety.
Furthermore, even though the contribution of traditional smoking to the pathogenesis of thrombotic diseases is
well documented, the involvement of e-cigarettes in such disease processes remains unknown. Consequently,
the present application outlines studies that address fundamental, mechanistic, epigenetic and clinically-relevant
translational aspects of the adverse-health effects of in utero exposure to e-cigarettes, an increasingly popular
form of tobacco, in the context of thrombotic disease and platelet biology, and in an e-liquid-, and sex-specific
manner. These studies are of paramount significance given the “perceived safety” of e-cigarettes, and will be
conducted using a novel/new whole body exposure model. The Aims of this proposal are:
Aim 1. Investigate the impact of in utero e-cigarette exposure on platelet-dependent disease states. While
there is compelling evidence that e-cigarettes do exert negative health effects, and that in utero exposure
to tobacco contributes to thrombogenesis, whether e-cigarettes are associated with an increased risk
of thrombotic diseases is yet to be determined. To address this issue, the consequences of in utero e-
cigarette exposure on normal hemostasis and whether it participates in the development of thrombotic
diseases will be determined. Subsequent studies will assess the impact of in utero e-cigarettes on clotting
factors.
Aim 2. Investigate the mechanism by which in utero e-cigarette exposure modulates platelet function. It
is noteworthy that published data shows that e-cigarettes do enhance platelet function (e.g., aggregation) in
adults. Nonetheless, it remains to be determined if in utero e-cigarettes produce similar effects or not. Thus,
the overall goal of the experiments proposed in this section is to determine the mechanism and impact of in
utero e-cigarette exposure on the various platelet functional responses, specific biochemical markers of
platelet activation, pro- and anti-inflammatory, as well as on the platelet epigenetics.
Collectively, these experiments will make major contributions to understanding the consequences of
in utero exposure to e-cigarettes on platelet activation and cardiovascular human health, its
epigenetics, and the mechanism by/through which they exerts these effects, in an e-liquid- and sex-
specific manner.

Public health relevance
Collectively, the studies proposed in the presented application, some of which are translational in nature, address mechanistic and fundamental concerns pertaining to the cardiovascular health effects of in utero exposure to electronic-cigarettes, an increasingly popular form of tobacco, by employing a systematic platelet function and related animal model and disease analysis approach, in the context of gender. Findings from these studies should lay the foundation not only for understanding, and advancing policy and means for evidence-based therapeutic management, but also for the prevention and control efforts of e-cigarette/tobacco- associated thrombotic disorders.